Core A: Administration

ABSTRACT
Core A will provide the leadership for scientific, administrative, fiscal, and organizational coordination of all the
activities of the Projects and Cores to ensure this Program Project Grant (PPG) meets all of the proposed
scientific goals. To coordinate scientific support, Core A will facilitate interactions and data sharing, provide
oversight, strategic planning and evaluation of the PPG. This will be accomplished through organizing: 1)
bimonthly meetings of the Executive Committee members consisting of the Project and Core leaders, 2) monthly
meetings of all Project investigators and Core leaders, 3) biannual meetings with the Internal Advisory Board
members, and 4) annual meetings with the External Advisory Board members, who will review progress of the
PPG as a whole. To coordinate administrative and fiscal support, Core A will provide 1) pre- and post-award
management, including monthly financial balances and expenditures, preparation of annual budgets and
projections, 2) assistance in annual progress reports on the PPG, including the written report of the EAB, and 3)
assurance that the PPG meets its reporting and compliance obligations. These face-to-face meetings will ensure
progress and data sharing, as well as uniformity in experimental protocols.

Public health relevance
NARRATIVE A successful Program Project Grant (PPG) relies heavily on an outstanding scientific program that is supported by an equally outstanding Administrative Core (Core A). Core A will (1) provide scientific, administrative, fiscal, and organizational coordination of all the activities of the Projects and Cores, (2) facilitate interactions and data sharing, and (3) provide oversight and strategic planning and evaluation for the program as a whole. Core A is an essential component of the PPG to allow the PPG investigators to achieve their scientific goals.